Red light mediated trafficking of microvesicles as a mechanism for vasodilation

This application is conceived on the premise that in certain diseases, e.g. peripheral artery disease (PAD),
traditional therapies are ineffective in the treatment of symptoms and related morbidities. PAD currently impacts
over 8 million Americans and will affect many more as our nation ages. The health care costs to treat subjects
are significant ($4 billion annually by Medicare), with most patients requiring numerous endovascular and
surgical procedures including amputation. Medical therapy has failed to impact the trend in this cost and efficacy
curve. This proposal seeks to change this paradigm by recognizing the endothelial dysfunction attributed to PAD
prevents proper blood flow recovery because the production of nitric oxide through its cognate enzyme nitric
oxide synthase is impaired. We have found nitric oxide (NO) precursors formed within endothelial vesicles to be
stimulated by red light energy to release NO and produce a stable NO bound vasodilator. Most importantly the
production and release of this autocrine factor dilates arteries/arterioles in the absence of nitric oxide synthase
(NOS). The actions of red light are clinically relevant, as we have identified significant elevations in blood flow
when the gastrocnemius muscle of healthy subjects and patients with PAD are exposed to red light. The
approach in this application will be to assess the production of these thiol based NO vesicles in healthy conditions
and oxidative stress by using ex vivo and cell culture techniques, characterize the intracellular mechanism for
vesicle transport and release of the NO precursor vesicle, and confirm our findings in vessels obtained from
human subjects with and without diseases predisposed to oxidative stress. We expect the data collected will
identify the mechanisms by which vesicles containing NO precursor molecules can be increased, improve
endothelial dysfunction and enhance perfusion. RELEVANCE TO VETERANS: PAD is a costly and highly
morbid disease which disproportionately affects our veterans. Red light has the potential to noninvasively
increase blood flow through the manipulation of intracellular NO precursors produced in vesicles. This finding is
a novel intervention which has great potential to reduce costs and improve symptoms by avoiding morbid surgical
procedures. The broader clinical impact of red light therapy cannot be fully realized until the mechanism by which
red light releases this vasodilator mechanism is identified.

Public health relevance
Effective treatments for peripheral artery disease and chronic limb ischemia are limited and leave veterans with chronic pain and possible amputation, since as a group they are at higher risk for these complications. Exposure of blood and muscle to red light increases blood flow by increasing nitric oxide through the secretion of S- nitrosothiols contained in endothelial vesicles. Understanding how light facilitates this secretion will help design new classes of drug therapies to help veterans with vascular diseases by producing a stable nitric oxide source. Further characterization of this cellular mechanism of nitric oxide release is a vital step in the expansion of red light therapy as a common treatment modality.